Administration Core

C. Description of Core Unit: The objectives of this core are to both provide administrative support and services to the Program Director and all of the investigators who are involved in the scientific undertakings proposed within this Program Project, as well as to unify and coordinate activities amongst the Program Project participants. This core will be responsible for all fiscal matters, the organization of internal meetings and seminars, the coordination of internal and external review of projects and cores, the provision of clerical support, assistance with statistical support for clinical studies, photographic services and dishwashing for Program activities, and budgetary assistance for the Program Personnel.